Generation and Description of Neuronal Morphology and Connectivity

Dendritic and axonal morphologies play fundamental roles in physiological brain function and pathological
dysfunction by affecting synaptic integration, spike train transmission, and circuit connectivity. Incorporating
published experimental data into accurate, full-scale, and biologically plausible neural network simulations is
important for quantitatively bridging the sub-cellular and systems-levels. We successfully designed,
implemented, and freely distributed to the community computer software and databases to reconstruct,
analyze, visualize, simulate, and share the 3D tree-like shape of neurons collected from any labeling and
visualization techniques, animal species, brain regions, developmental stages, and experimental conditions.
We imaged by light microscopy, digitally traced, and shared new data, and we provided our peers with the
electronic means of freely doing the same. Moreover, we combined those data with computational models of
membrane biophysics to investigate the neuronal structure-activity relationship with a special focus on the
hippocampus and entorhinal cortex due to their central role in spatial representation and episodic memory. We
additionally annotated a massive amount of cellular properties in an open-source web-based portal of neuron
types in the rodent hippocampal formation. We now propose to expand this research approach with three
specific aims. The first is to augment the power, scope, and usability of the NeuroMorpho.Org repository of
digital tracings. We plan to more than double the number of shared reconstructions while enhancing the
human- and machine-accessible utility by adding ‘search similar’ and summary reporting functionalities. Most
importantly for long-term sustainability, we will dramatically modernize the information technology infrastructure
of this resource to enable unsolicited submissions directly from authors, continuous agile releases, and
community crowdsourcing. The second aim is to complete the Hippocampome.org knowledge base by adding
synaptic information, including connection probabilities, physiology, and plasticity, and linking them to the
existing morphological, physiological, and molecular properties of pre- and post-synaptic neurons. This will
enable the implementation of a real-scale spiking neural network model to run predictive simulations of activity
dynamics and computational functions. The third aim is to develop an innovative approach to classify neurons
directly from network connectivity, validating it with the hippocampal circuit and deploying it on open-access
high-throughput data from a popular model organism. Together, these three aims will allow us (and others) to
test hypotheses relating neuronal morphology to molecular and developmental determinants on the one hand,
and to functional circuits on the other. The focus of this application on structural plasticity is especially relevant
to disabling neurological diseases prominently involving the hippocampal formation, including epilepsy and
Alzheimer’s. Our proposed data-driven, biologically realistic network simulations may shed light on the role of
specific neuron types and of their interactions in impairments of memory formation and retrieval.

Public health relevance
Generation and Description of Neuronal Morphology & Connectivity Brain connectivity and the intricate tree-like shape of individual nerve cells underlie cognitive and physiological functions, and are dramatically altered in almost all known neurological disorders. Using state-of-the-art information technology, data mining, and computational modeling, this project will synthesize, analyze, and freely share a massive amount of quantitative information on neuronal morphology and on the synaptic properties of an exemplary neural system responsible for spatial representation and autobiographic memories. These developments will enable the creation of detailed, biologically plausible, full-scale, quantitatively predictive neural network models to investigate the circuit dynamics of learning and related impairments for the long-lasting benefit of scientific advancement and public health.